Optimizing HER2-targeting using RNA- and DNA-based predictive algorithms

ABSTRACT
HER2-positive disease, which comprises 20% of all breast cancers, is among the most aggressive but
treatable forms. Outcomes for HER2-positive patients have been transformed by the development of several
highly effective HER2-targeting agents that are given broadly for stages I-IV HER2+ breast cancer either as
single agents or as dual HER2-targeting. These drugs have reduced death rates from this disease by nearly
40%, however come at a high financial cost – all HER2-targeted drugs individually cost at least $100,000 per
year. We also clearly overtreat many of the approximately 40,000 non-metastatic patients diagnosed with
HER2-positive breast cancers in the U.S. each year. Most of the treatment regimens used in stages I-III HER2-
positive breast cancer include polychemotherapy with 2-3 cytotoxic drugs plus 1-2 HER2-targeted drugs given
for 1 year.
Genomic studies from large randomized trials provide opportunities for improvement. Several studies have
found that tumor and microenvironmental influences are major contributors to variability in response and
outcome. RNA- and DNA-based studies from CALGB 40601 and other neoadjuvant trials of HER2-targeting
agents suggest that tumor intrinsic molecular subtype and immune cell activation are at least as important as
treatment type in determining outcome and can identify tumors that respond best to single or dual HER2-
targeting. These studies suggest a way to more thoughtfully and rationally treat HER2-positive breast cancer
patients, but we must do this collaboratively and comprehensively.
We propose to collectively integrate and analyze the clinical, gene expression, gene aberration, response to
therapy, and outcomes data from more than 1500 women participating in multiple randomized neoadjuvant
clinical trials of HER2-targeted therapy. We will examine the role of tumor and microenvironmental factors in
determining response to HER2-targeting, relationship of pathologic complete response to outcome, and the
biology of residual disease after dual or single HER2-targeting in HER2-positive breast cancer.

Public health relevance
PROJECT NARRATIVE We propose to comprehensively examine the role of tumor and microenvironmental factors determining sensitivity to HER2-targeted treatment regimens and outcomes including pathologic response (pCR) and event-free survival (EFS), in HER2+ disease. We will integrate RNA- and DNA-sequencing results of over 1500 HER2+ breast cancers from multiple neoadjuvant clinical trials in order to: a) determine the value of genomic subtype in predicting response to HER2- targeting and b) evaluate the relationship of response to HER2-targeting and event-free survival and clarify the tumor and microenvironmental features that affect this relationship.